Effects of tDCS Paired with Cognitive Training on Brain Networks associated with Alcohol Use Disorder in Veterans

Alcohol misuse is an epidemic among Veterans in the United States. Nearly 1/3 of Veterans have a lifetime
history of Alcohol Use Disorder (AUD). Across Veteran and civilian populations, about 60% of those entering
treatment will relapse within one year. Paradoxically, chronic alcohol use is associated with cognitive
impairments and changes in their underlying neural circuitry, that interfere with adaptive behavior needed for
successful recovery. However, these cognitive impairments and their underlying neural substrates are
promising new targets for interventions that can reduce relapse rates. Evidence suggests that cognitive training
can improve cognition in individuals with AUD, strengthen neural networks mediating cognition, and improve
treatment outcome. However, cognitive training is effort intensive, has small effect sizes, and may have limited
durability.
Evidence suggests that addiction is mediated by a dysfunctional cortico-striatal neurocircuitry characterized by
excess striatal activity (driving substance use) coupled with hypoactive prefrontal cortex (impaired cognitive
control)​.​ Resting-state functional connectivity (RSFC) data has identified a promising circuit-based target for
the treatment of addiction. Individuals who have achieved long-term abstinence from alcohol (~7 years of
abstinence) have higher RSFC in prefrontally-mediated networks (e.g. prefrontal-striatal, prefrontal-parietal,
prefrontal-insular, prefrontal-thalamic networks) th​an controls or those with short-term abstinence (6-10 weeks
of abstinence). Moreover, lower prefrontal RSFC during short-term abstinence can predict subsequent relapse.
The ​primary objective​ of this study is to investigate the use of a novel neuroplasticity based intervention that
combines ​cognitive training​ and ​transcranial direct current stimulation ​(tDCS) neuromodulation​ to enhance
frontal-striatal RSFC and cognition, with the goal to improve treatment outcomes and increase abstinence in
Veterans with AUD.
This research proposal will address the following ​Specific Aims (SAs)​: ​SA1) ​Compare brain network changes
between active tDCS vs. sham tDCS (placebo) groups, ​when both groups receive cognitive training​. RSFC
changes will be measured with functional magnetic resonance imaging data collected pre- and
post-intervention. ​Hypothesis:​ ​Active tDCS, compared to sham tDCS will produce a significantly greater
increase in prefrontal-striatal RSFC. ​SA2) ​Evaluate cognitive changes between active tDCS vs. sham tDCS
(placebo) groups. ​Hypothesis:​ ​Active tDCS, compared to sham tDCS, will produce a significantly greater
improvement in cognitive performance measures. ​SA3) ​Compare the effects of active tDCS vs. sham tDCS on
drinking behavior over a 2 month follow-up period.​ ​Our primary outcome will be to compare binge drinking days
per week​ w​ ithin the 2 months after the intervention between AUD participants who receive active tDCS vs.
sham. ​Hypothesis:​ ​Active tDCS, compared to sham tDCS, will produce significantly fewer binge drinking days
per week​ i​ n the 2 months following the intervention.
Cognitive impairment and its underlying neural mechanisms affect alcohol addiction​ treatment outcomes​. We
propose the first study to examine how tDCS-augmented cognitive training affects cognition and its related
brain circuitry in alcohol use disorder in Veterans, which will provide critical information to guide future research
and treatment development.

Public health relevance
Alcohol misuse is an epidemic among Veterans in the United States. Nearly 1/3 of Veterans have a lifetime history of Alcohol Use Disorder (AUD). Across Veteran and civilian populations, about 60% of those entering treatment will relapse within one year. Paradoxically, chronic alcohol use is associated with cognitive problems and changes in their underlying brain circuitry, that interfere with adaptive behavior needed for successful recovery. The primary objective of this study is to investigate the use of a novel neuroplasticity based intervention that combines cognitive training and transcranial direct current stimulation (tDCS) neuromodulation to enhance brain connectivity and cognition, with the goal to improve treatment outcomes and increase abstinence in Veterans with AUD. This research proposal is the first study to examine whether the combined effect of cognitive training plus brain stimulation can affect brain networks in Veterans with AUD, which will provide critical information to guide future research and treatment development.